Impact of Aging on Mucosal Immune Protection in the Female Reproductive

Project Summary/Abstract
An urgent need exists to understand the impact of aging on mucosal immunity in the female reproductive tract
(FRT) of postmenopausal women, given the increased risk of infections and the lack of knowledge of immune
alterations that occur as women age. Recognizing that menopause and the accompanying absence of sex
hormones fundamentally alters the immune environment in the FRT, the overall goal of this proposal is to arrive
at a mechanistic understanding of how aging (50-59, 60-69 and >70yrs) impacts pathogen recognition, immune
protection and induction of immune responses in the upper and lower FRT. This proposal has 3 original Aims:
1) Determine the extent to which aging compromises immune protection by FRT epithelial cells. As
epithelial cells are the first line of defense against pathogens, we will identify the extent to which pattern
recognition receptor (PRR) signaling by epithelial cells is compromised with aging. We will also determine age-
dependent changes in secreted innate molecules with antimicrobial and chemotaxis capacity.
2) Determine the impact of aging on local immune protection by evaluating resident and non-resident
T cell function throughout the FRT. In this Aim, we will evaluate age-dependent changes in cytotoxic activity
and secreted immune responses (antimicrobials and cytokines) following activation of CD4+ and CD8+ tissue
resident and non-resident T cells throughout the FRT.
3) Determine the impact of aging on dendritic cell (DC) pathogen recognition and induction of T cell
responses throughout the FRT. This aim will identify age-associated changes in PRR responses by DCs and
in DC's ability to induce T cell responses, as well as the mechanisms that control DC function as women age.
This study is unique in that it integrates aging with our understanding of the innate and adaptive mucosal immune
system throughout the human FRT, as it relates directly to mucosal protection by the very cells most likely to
interact and respond to pathogens. These studies will provide much needed information that is essential to
identify age-related changes in immune function in the FRT and influence responses to urinary tract infections
(UTIs) and sexually-transmitted infections (STIs). As older women are generally excluded from prevention
research for STIs, and vaccination recommendations (for example HPV), our studies will provide a foundation to
define mucosal immune protection in elderly women and develop appropriate strategies for the prevention of
new infections and pathogen reactivation.

Public health relevance
PROJECT NARRATIVE To improve morbidity and mortality in elderly women, the changes in protection against infections that take place as women age need to be identified. This proposal will investigate how aging affects defense mechanisms in the female reproductive tract (FRT) that protect against genitourinary infections. The identification of the mechanisms that control protection against FRT infections in elderly women will open new pathways for the development of prevention strategies.